Device Automation of an FDA-cleared CD-Microfluidic Platform for Rapid Tissue Microsizing

ABSTRACT
There is a need in the market for a true platform technology that automates the tissue
processing experience. Syntr Health Technologies has dedicated the last six years developing
the technology that can streamline tissue processing. Our FDA-cleared SyntrFuge System and
SyntrFPU360, is a platform technology that can process a variety of different tissue types such
as cancer tumors of kidney, liver, brain, and breast tissue by dissociating them into single cells
to better understand tumor tissue heterogeneity, of which the single cell analysis market is
valued at $3.3 Billion and expected to grow to $6.3 Billion by 2026. As well, our platform can be
used to microsize autologous adipose tissue to be used for reinjection back into the patient to
treat medical conditions of the aging population such as diabetic foot ulcers and knee
osteoarthritis. Syntr has successfully completed an SBIR Phase I grant where we utilized
micronized adipose tissue to heal diabetic ulcers in an animal model. This study had an
important role in developing a treatment modality that translated successfully into humans.
Preliminary human clinical data is showing significant diabetic foot ulcer wound closure within 3-
5 weeks using autologous adipose tissue processed in our platform. The diabetic foot ulcer
market is currently valued at $1.98 Billion with a CAGR of 8.2%. This high growth potential is
attributed to the increase of the diabetic population. Additionally, the use of microsized adipose
tissue is showing great promise in intra-articular injections to knee joints for the treatment of
osteoarthritis (OA). The knee OA market in North America is currently valued at $5.9 Billion and
growing at t CAGR of 8.8%. Over 88% of individuals with OA are 45 or older. The high growth
potential of this market is largely attributed to the increase of the aging population along with the
increase in obesity rates. Our platform technology for the rapid processing and/or microsizing of
tissues can disrupt these markets in a major way. The automation of this technology in this
Phase I SBIR is paramount to increase favorability in the adoption of this much needed
technology in various medical fields..

Public health relevance
Project Narrative Automation is key for usability in a clinical setting to help reduce user interaction, provide repeatability and reproducibility, and maintain cleanliness. This project will automate an FDA-registered system for microsizing autologous adipose tissue for the use in regenerative medicine, as well as for dissociating tumor tissue into single cells for cancer diagnostics. This project will provide a valuable role in developing a fully automated system for the use in multiple medical procedures in the regenerative medicine field.